DIAGNOSIS AND TREATMENT OF ADVERSE REACTIONS TO FOODS AND ADDITIVES

We challenged 13 non asthmatics and 30 asthmatics with monosodium glutamate (MSG). Asthma was classified on the basis of clinical history and steroid use. MSG was administered as a graded single blind oral challenge followed by a placebo-controlled double-blind oral challenge in patients with pulmonary reactions during the single-blind challenge. Medications were withheld prior to study. MSG was administered in capsules containing increasing dosages of MSG at 30 min intervals for a total dose of 7.6 gm. A positive test was defined as a decrease in the FEV1 of greater than 20%. None of the non asthmatic subjects had any change in pulmonary parameters, and only 1 of 30 asthmatics had a significant drop in FEV1 (22%). This patient was entered into the double-blind challenge and no decrease in FEV1 was observed. We concluded that the ingestion of 7.6 gm of MSG over 2 hr or 6.0 gm at a single dose poses no consistent respiratory hazard to normal subjects and to the asthmatic population represented in this study. Interleukin-5 (IL-5), a lymphokine released by specific subsets of T cells following activation, is thought to be an important factor in eosinophil maturation and function. To determine whether local production of IL-5 by T cells in the mucosa could play a role in diseases characterized by mucosal eosinophilia, we have developed a sensitive and specific semiquantitative assay for IL-5 mRNA transcripts in mucosal biopsies. IL-5 mRNA was detected in gastric endoscopic biopsies from patients with eosinophilic gastroenteritis with multiple food allergies, but not in normal gastric mucosa. These results suggest T cell activation and production of IL-5 may play an important role in eosinophilic gastroenteritis.